NATURAL HISTORY OF HIV 1 INFECTION IN A LONGITUDINAL COHORT OF GAY/BISEXUAL MEN

Ongoing natural history study of the transmission, clinical manifestations, immunologic and virologic characterizations of HIV-1 infection.